LYSYL OXIDASE GENE MUTATIONS IN COLON CANCER

The overall goal of this proposal is to define the role of new putative tumor suppressor gene located at the q23 locus on human chromosome 5 in the development of colon cancer. Lysyl oxidase is a multifunctional, copper-dependent amine oxidase responsible for the development of lysine-derived crosslinks in the extracellular matrix proteins, collagen and elastin. Over the last five years, several groups of investigators, including ourselves, have shown that this enzyme also exhibits a ras-related growth regulatory function. We have recently completed the detailed characterization of the entire human lysyl oxidase gene, including the localization of this gene to the q23 region of chromosome 5 and the identification of two informative polymorphic markers within exon 1 and 10kb upstream of the lysyl oxidase gene. These polymorphisms were used to establish loss of heterozygosity within the 5q23 locus in tumor DNA from approximately 20% of a cohort of 98 patients diagnosed with colorectal cancer. Moreover, in three of these patients, a lysyl oxidase gene mutation was identified in the surviving allele in these tumor DNA samples. This data supports our hypothesis that deletions and mutations at 5q23, involving a new putative tumor suppressor encoded by the lysyl oxidase gene, are involved in the development of colon cancer. This proposal seeks to characterize these 5q23 rearrange- ments in order to begin to understand the role of lysyl oxidase gene mutations in the cascade of genetic events that lead to colorectal tumorigenesis.